Administrative Core

PROJECT SUMMARY
The Administrative Core is the mechanism by which decisions of the Executive Committee and the advice of the
External Scientific review are operationalized through the Cores and the Project investigators over the five-year
funding period. It operationalizes decisions on scientific priorities and goals for the Center, reviews resource
allocation and monitors research progress. It is also the avenue by which day-to-day matters, which arise in the
context of the implementation and conduct of individual projects and Cores, can be addressed. Procedures to
facilitate these functions and optimize communication have been established in order to allow Directors of the
Scientific Core and the Principal Investigators of individual projects to have ready access to needed information,
to permit prompt decision-making on fiscal matters, and to determine and allocate scientific and clinical resources
for all projects and cores to achieve the designated scientific goals. This core manages the website which has
been set up but needs ongoing content review and refreshment. The Core also oversees the Research Training
and Summer Research Experience Program. The director of that program is Co-I for that purpose on
Administrative Core. A system for selecting undergraduates for summer research electives and for post-doctoral
fellows is described. The program will be publicized and a data base tracks the future career trajectory of
awardees.